DELAVIRDINE MESYLATE WITH DIDANOSINE VS DDI ALONE IN HIV1 SUBJECTS

This study will test whether delavirdine in combination with didanosine is safe and effective in the treatment of patients with the human immuno-deficiency virus.